RADIOLABELED IMMUNOGLOBULIN THERAPY OF HUMAN CANCER

Radiolabeled immunoglobulin therapy (RIT) produces partial and complete regression of cancer in some patients. Analyses of clinical trails and experimental data suggest specific areas of research to improve this therapy and extend its applications to a wider spectrum of malignancies. We now propose to study RIT in a detailed and coordinated research program.